Defining the impact of type 1 cytokine signaling on STAT-mediated epithelial reprogramming and barrier dysfunction in eosinophilic esophagitis

PROJECT SUMMARY
Eosinophilic esophagitis (EoE) is a chronic inflammatory condition of the esophagus triggered by an immune
response to food antigens. Despite effective treatment that leads to histologic remission, there are persistent
changes in mucosal gene expression, epithelial differentiation, and histologic anomalies, including basal cell
hyperplasia. Recent findings from other tissue sites indicate that mucosal inflammation can induce chromatin
remodeling via immune signaling, including the JAK/STAT pathway. However, the mechanisms governing
chromatin remodeling and persistent remodeling in the esophagus remain unknown. IL-4/IL-13 signaling via
signal transducer and activator of transcription 6 (STAT6) has been shown to cause epithelial barrier dysfunction
in EoE. However, emerging data suggests that other STATs may be involved in EoE. These include STAT3, which
is also downstream of the type II IL-4 receptor, and STAT1. We have recently shown there is upregulation of
interferon signature genes in the esophageal epithelium during EoE, indicating that there is dysregulation of
multiple STAT pathways within the epithelium during EoE. Here, we will examine the specific roles of STAT3 and
STAT1 in regulating STAT6-driven epithelial barrier function. We will determine the extent to which (1) coordinate
activation of STAT1 via IFN-g will antagonize STAT3 and STAT6-mediated effects, and (2) coordinate activation
of STAT3 and STAT6 will have synergistic effects. We generate human epithelial knockout lines (STAT1KO, STAT3
KO) using CRISPR-Cas9 and will interrogate the specific interactions of STAT1 and STAT3 on STAT6-mediated
gene expression, chromatin remodeling, and epithelial barrier dysfunction. We will create novel epithelial
conditional STAT1 and STAT3 knockout mice to evaluate the respective role of each transcription factor within
the complex inflammatory milieu of EoE. The proposed experiments will advance understanding of the crosstalk
between T1 and T2 cytokine signaling and epithelium in the esophagus. We will examine regulatory networks
that impact JAK/STAT signaling within the epithelium and tissue-specific transcription factor behavior and its
impact on chromatin remodeling. This work will identify key molecular drivers of persistent symptoms, paving the
way for novel therapies for patients with esophageal remodeling and persistent symptoms. By addressing
mechanisms that lead to chronic tissue remodeling and dysfunction, this study could ultimately improve long-
term health outcomes for EoE patients, contributing to the goal of enhancing the quality of life for those with
immune-mediated diseases.

Public health relevance
PROJECT NARRATIVE Eosinophilic esophagitis (EoE) is a chronic immune-related disorder of the esophagus that exhibits persistent epithelial remodeling once the inflammation has subsided. This project will investigate the specificity of JAK/STAT signaling mechanisms in esophageal epithelium and determine how interactions between these pathways impact durable chromatin remodeling and impaired barrier function in EoE. These findings could lead to therapies that more effectively address epithelial dysfunction and persistent symptoms in EoE and potentially offer insights into other chronic inflammatory diseases.